Neurophysiological investigation of the approach-avoidance axis in OCD: applications to neuromodulation

Obsessive-compulsive disorder (OCD) has a lifetime prevalence of 2-3% and is a major cause of global disability.
OCD is characterized by obsessions (i.e., unwanted intrusive thoughts) and compulsions (i.e., repetitive ritualistic
behaviors) and exemplifies a pathologically avoidant phenotype where greater degrees of avoidance are
associated with greater symptom severity and treatment resistance. In the 20-40% of OCD patients that are
treatment refractory, deep brain stimulation (DBS) of the ventral capsule and ventral striatum (VC/VS) is an
effective therapy that achieves significant benefit in 66% of patients.
While VC/VS DBS does not acutely relieve OCD symptoms, DBS often produces a “pro-approach” response
including an increase in talkativeness, a desire to engage in activities, extroversion, and affiliative behavior. Our
central therapeutic hypothesis is that VC/VS DBS achieves eventual benefit in OCD by providing the “boost” in
pro-approach behavior that allows individuals to overcome their pathological fear-based avoidance. Thus, we
focus on the approach-avoidance axis as one of the critical neurobehavioral axes underlying the pathophysiology
of OCD. Our overall goal is to develop a mechanistic understanding of DBS for OCD by rigorously investigating
the relationship between clinical symptoms, behaviors (i.e., approachful vs. avoidant), and neurophysiology.
Based on our preliminary data from on-device DBS recordings in OCD patients, we hypothesize that greater
variability in neural activity in the VS, a structure known to influence motivated goal-directed behavior, allows the
agent to shed maladaptive ritualistic behavior in favor of reasoned behavior aligned with long-term goals. In other
words, the transition from repetitive, ritualistic actions in the symptomatic state to more adaptive and flexible
behaviors after response is accompanied by increased dispersion and decreased predictability of VS activity.
In 10 patients with recording-capable DBS devices, we will collect a broad array of neurobehavioral data in
the clinic and the home. The first 2 Aims test our hypothesis by studying the pattern of VS neural activity in the
controlled environment of the lab/clinic during two complementary paradigms: one based on a psychophysical
behavioral task, the other based on exposure and response prevention, a therapeutic behavioral intervention.
The third aim tests this hypothesis in an ambulatory, naturalistic setting with chronic neural on-device recordings
paired with time resolved behavioral measures from wearables (e.g., sleep, heart rate, activity) and video diaries
(e.g., facial affect, speech). We will investigate a possible common neural basis underlying approach and
avoidance across these 3 paradigms. These data will allow us to use VS intracranial recordings to inform and
validate the approach-avoidance framework and investigate the degree of explanatory power this framework has
for OCD. By understanding the therapeutic mechanism driving OCD symptom improvement after VC/VS DBS,
we will pave the way for rigorous, data-driven neuromodulatory strategies to regulate behavior and ameliorate
symptoms in other disorders characterized by dysregulated approach-avoidance behavior.

Public health relevance
Project Narrative Despite FDA approval for deep brain stimulation (DBS) for obsessive-compulsive disorder (OCD) in the form of a Humanitarian Device Exemption, this therapy remains underutilized and poorly understood. Based on the pathologically avoidant phenotype underlying OCD and the pro-approach behavior required to overcome fear- based avoidance, we conceptualize our study of the neurophysiological underpinnings of OCD by tracking behavior and ventral striatum neural activity along the approach-avoidance axis. Doing so would create a foundational understanding of the neurobehavioral effects of DBS that will generalize to other disorders characterized by dysregulation of behavior along the approach-avoidance axis.